Gene silencing in Fragile X syndrome

Background: Fragile X mental retardation syndrome (FXS) is the most common heritable cause of intellectual disability and the most common known cause of autism. Other symptoms of FXS include depression, sensory processing deficits, aggressive behavior, connective tissue problems and digestive difficulties. This disorder arises when the number of CGG-repeats in the 5 UTR of the FMR1 gene exceeds 200. Such alleles become silenced. This results in a deficiency of the protein product of this gene, FMRP, which is involved in the regulation of translation of a subset of mRNAs. The FMRP deficiency in brain results in aberrant dendritic spine morphology and a defective response to synaptic activation. The mechanism of gene silencing is unknown. Progress report: We have previously identified a number of steps in the gene silencing process including some that precede DNA methylation and some that occur very late in the silencing process (Biacsi, Kumari and Usdin, 2008). One of the late steps in FX gene silencing turns out to be the deacetylation of histone H4 on lysine 16, a step we showed to be carried out by SIRT1, a class III histone deacetylase. We have shown that SIRT1 inhibition reactivates the FMR1 gene without requiring DNA demethylation (Biacsi, Kumari and Usdin, 2008). It may thus be useful in cells like neurons where the effect of gene silencing is most apparent. More recently we have shown that the silenced allele is associated with both marks of facultative and constitutive heterochromatin (Kumari, Biacsi and Usdin, 2010). The constitutive heterochromatin marks are enriched in the vicinity of the repeat. This indicates that the trigger for FMR1 gene silencing may be intrinsic to the repeat. The marks of facultative heterochromatin have a more broad distribution across the 5' end of the gene. Both normal and patient alleles have a heterochromatin block upstream of the FMR1 promoter that contains these 2 histone marks but not the marks of constitutive heterochromatin. It may be that the heterochromatic changes initiated by the repeat trigger the loss of function of a boundary element located in this region. This in turn allows the spread of the facultative heterochromatin marks into the FMR1 gene. This may in essence introduce a second set of repressive heterochromatin marks that act to reinforce gene silencing. Our more recent work has focused on using patient-derived Induced Pluripotent Stem Cells to understand the gene silencing mechanism and search for reagents that are able to alleviate this silencing.